NCTN BIQSFP Supplements 2020

This is a supplement application for Biomarker, Imaging and Quality of Life Studies Funding Program (BIQSFP) funding for the following SWOG Cancer Research studies: S1500, S1602, S1608, S1613, S1803, S1827 and S1929.

Public health relevance
This is a supplement application for Biomarker, Imaging and Quality of Life Studies Funding Program (BIQSFP) funding for the following SWOG Cancer Research studies: S1500, S1602, S1608, S1613, S1803, S1827 and S1929.